Function and Regulation of DNA Replication Origin Firing Factors

ABSTRACT
DNA replication is a highly dynamic and deeply regulated process during which thousands of replication
origins will fire. The efficiency of these origin firing events is highly variable across genomic regions and
changes throughout S-phase. This variability in origin firing efficiency carries profound implications, as its
deregulation leads to genome instability and cancer. Despite its critical importance, our current
understanding of the fundamental mechanisms governing these variable origin firing efficiencies at
different genomic locations and times during S phase remains surprisingly limited. This proposal’s overall
objective is to address critical gaps in understanding the regulation of origin firing efficiency, focusing on
the recruitment of two essential origin firing factors called TICRR/TRESLIN and MTBP, to replication
origins throughout the cell cycle. The research proposal seeks to complete three specific aims: 1)
Determine the mechanisms for replication origin selection by TICRR and MTBP; 2) Define roles for
transcription factors and chromatin modified in determining where replication factors bind and replication
origins fire; 3) Uncover how TICRR/TRESLIN and MUVB-MYBL2 functionally interact to coordinate mitotic
entry with the completion of DNA replication. The applicant has created a series of human cell lines that
will serve as ideal models for elucidating the mechanism of action for specific replication initiation proteins
through approaches including flow cytometry-based assays, Cut&Run, Optical Replication Mapping,
ChIP-qPCR and SLAM-Seq. In Aim 1, the applicant will examine the specific contributions of TICRR and
MTBP to origin site specification as cells progress from G1 to early and late S-phase. Aim 2 will test
whether origin site specification depends on physical interactions, which the applicant discovered,
between TICRR and a transcription factor and histone acetylation reader proteins. Aim 3 will examine the
coordination of gene activation of G2/M genes with the completion of DNA replication using both cultured
human cells and zebrafish embryos. This coordination is crucial for cell cycle progression, yet it remains
under-researched, highlighting its potential impact. The overall research in this proposal
is innovative because it examines a mechanism by which cells actively control the activation of replication
origins and coordinate the completion of DNA replication with mitotic entry. Successful achievement of the
aims presented in this grant will be significant because it will help answer long-standing, fundamental
questions about how the genome is accurately and completely replicated. Importantly, the studies are
focused on delineating mechanisms that may be manipulated for treating diseases such as cancer.

Public health relevance
PROJECT NARRATIVE The replication initiation complex is responsible for triggering the onset of DNA replication during each round of cell division. Deregulation of this process can lead to genomic instability and is a first step to tumorigenesis and developmental disorders. Our research will address how the number of replication sites in the genome are selected and properly regulated to ensure that the whole genome is copied prior to the completion of cell division.